Cardiometabolic effects of genetically decreased dipeptidyl peptidase-4 (DPP4) (Grant Transfer from UPENN)

PROJECT SUMMARY/ ABSTRACT
Cardiovascular disease is the leading cause of morbidity and mortality for patients with type 2 diabetes
(T2DM). Determining cardiovascular effects of T2DM therapies is of clinical importance. Human genetics may
be a strategy to provide insights to long-term effects of T2DM therapies and mechanisms linking T2DM and
cardiovascular risk. Dipeptidyl peptidase 4 (DPP4) inhibitors are used for the treatment of T2DM and decrease
degradation of substrates with possible metabolic or cardiovascular effects such as glucagon like peptide-1
(GLP-1), neuropeptides, CXCL12, brain natriuretic peptide, and substance P. Although they have the benefit of
improving glucose dynamics through GLP-1 effects, DPP4 inhibitors are also associated with increased risk of
hospitalization for heart failure (such as during saxagliptin), potentially related to negative effects of
neuropeptides, CXCL12, and substance P. Long-term data on cardiovascular effects of DPP4 inhibition remain
limited as the longest cardiovascular outcomes trial of DPP4 inhibitors was only three years. Our preliminary
data in among individuals in the Penn Medicine Biobank show that on gene burden analysis for rare loss of
function variants, DPP4 loss of function was significantly associated with heart failure. Phenotyping individuals
with DPP4 loss of function will provide further insights as to the possible mechanism for this finding and long-
term effects of decreased DPP4 activity and antigen in humans.
We hypothesize that genetic DPP4 loss of function will be associated with improved metabolic
parameters but also with heart failure and related biomarkers/ imaging. We will identify individuals in the Penn
Medicine Biobank with DPP4 loss of function variants and their matched controls and recruit them for a
phenotyping study. We will also enroll participants in a pilot clinical trial to assess the response of individuals
heterozygous for DPP4 loss of function to pharmacologic DPP4 inhibition.
The candidate has a strong multi-disciplinary mentoring team with experts in patient oriented research,
genetics, endocrinology, cardiology (advanced heart failure), mathematical modeling/ biostatistics, and
metabolomics/ proteomics. The candidate will gain necessary skills and expertise during the award period in
the areas of: genetics, a genetic-based approach to clinical trials recruitment, mathematical modeling of insulin
sensitivity and insulin secretion, advanced biostatistics, and leadership skills. This will facilitate the candidate
achieving necessary milestones to become an independent academic physician-scientist specializing in the
use of genetics and clinical trials approaches to answer questions in T2DM and metabolism, cardiovascular
risk, and related therapies.

Public health relevance
PROJECT NARRATIVE Dipeptidyl peptidase 4 (DPP4) inhibitors are commonly used for the treatment of type 2 diabetes, however, decreased DPP4 activity may also increase the risk of heart failure. In this proposal, we will phenotype adults with DPP4 loss of function variants (thus genetically decreased DPP4 activity and antigen) compared to matched controls, and in a pilot study we will assess the response of individuals heterozygous for DPP4 loss of function variants to pharmacologic DPP4 inhibition. Data generated from this proposal will allow us to better understand underlying pathophysiology and potential long-term cardiovascular and metabolic effects of decreased DPP4 in humans.